Mechanisms of persistence of Clostridioides difficile in the intestinal mucosa

PROJECT SUMMARY/ABSTRACT
Clostridioides difficile is a Gram-positive, spore forming and strictly anaerobic and pathogenic bacterium
that is the leading cause of antibiotic-associated diarrhea worldwide. C. difficile infections (CDI) are highly
contagious, difficult to treat and prevent recurrence of the infection. There are several critical gaps in our current
knowledge of the molecular mechanisms of persistence of C. difficile spores during CDI-treatment that lead to
recurrence of the infection. Our long-term goals are to elucidate how C. difficile spores interact with the intestinal
mucosa to facilitate spore-persistence and how these interactions lead to disease recurrence. Our previous
studies revealed that C. difficile spores internalized and adhered in intestinal epithelial cells act as a reservoir for
the recurrence of the infection. These results lead to our central hypothesis: that C. difficile spores combine
intracellular and adherence mechanisms to persist in the intestinal mucosa during infection and treatment, to
drive disease recurrence. Towards this hypothesis, we found that C. difficile spores internalize into intestinal
epithelial cells (IECs). During vancomycin treatment of C. difficile-infected mice, we observed in ileal, cecum,
and colonic samples, significant persistence of adhered and intracellular C. difficile spores. We observed that C.
difficile spores interact, in a concentration dependent manner, with the extracellular matrix proteins fibronectin
(Fn) and vitronectin (Vn), and uses them as molecular bridges to gain entry into IECs in an a5b1 and avb1 integrin-
dependent manner. The spore surface protein, BclA3, is essential for spore entry into IECs via the Fn/Vn-integrin
pathway. BclA3 contributes to disease recurrence, apparently by enhancing spore adherence to the intestinal
mucosa. Administration of the cholesterol-sequestering agent, nystatin, strongly attenuated spore entry into IECs
in an ileal and colonic loop mouse model, while administration of nystatin during vancomycin treatment of C.
difficile-infected mice diminished disease recurrence in mice. Our results also show that E-cadherin interacts
with C. difficile spores and plays a role in spore-adherence to IECs, and that E-cadherin-mediated spore-
adherence to IECs is enhanced by toxin-mediated damage, which may also play a role in recurrence of CDI.
Guided by our strong preliminary data, we propose to pursue three Specific Aims to characterize the mechanism
underlying the interactions between C. difficile spores and the intestinal mucosa that contribute to recurrence of
the infection: (1) Dissect the mechanism of internalization of C. difficile spores into intestinal epithelial cells; (2)
Determine the role of adhered and intracellular spores in C. difficile persistence and disease recurrence; (3)
Investigate the impact of toxins in E-cadherin-mediated C. difficile persistence and infection recurrence.
Completion of these aims may expose novel targets for decolonization, therapeutics, and vaccine strategies to
combat this pathogen.

Public health relevance
PROJECT NARRATIVE Clostridioides difficile spores are recognized as the morphotype of infection, persistence and transmission. Our proposed studies aim to understand the interactions between C. difficile spores and the host ́s intestinal mucosa that contribute to C. difficile persistence and recurrence of the infection. This research will reveal novel therapeutic targets from both, pathogen and host, to treat C. difficile infections and prevent disease recurrence.